Community Engagement Core

Project Summary
Community-engaged research (CEnR) is becoming increasingly viewed as a keystone to translational
medicine and plays an integral role in accomplishing the NIEHS Strategic Goals. The Community Engagement
Core (CEC) is a key integrating element in the University of Cincinnati (UC) Center for Environmental Genetics
(CEG). The core has the major responsibility of assisting CEG investigators in fostering mutually beneficial,
bidirectional partnerships with community members, health care professionals, and policy makers involved in
environmental health science (EHS). The ultimate goals of the CEC are to increase awareness and
understanding of CEG EHS research, and serve as a liaison between the community and the Center. In order
to achieve these goals and in support of the vision of the CEG to “minimize the impact of environmental
exposures on health”; the CEC will innovatively address three specific aims. Specific Aim 1: Translate and
disseminate Center research into environmental public health knowledge for our target audiences (community
members, health care professionals, and policy makers) in order to increase awareness and understanding of
environmental health. Specific Aim 2: Develop and facilitate bidirectional community-engaged research
partnerships between Center investigators and members of our target audiences in order to address identified
environmental health issues, needs, and concerns. Specific Aim 3: Advance the field of community
engagement in environmental health through implementing citizen science practices, novel communication
approaches, and data disclosure. With expertise in public health, outreach and education, and environmental
health communication, the highly active and committed CEC community-academic leadership team in
partnership with its Stakeholder Advisory Board (SAB) is poised to significantly contribute to seven of the 11
NIEHS Strategic Goals (#5, 6, 7, 8, 9, 10, and 11). The innovative ability of the CEC to leverage and expand
existing UC resources for EHS, integrate with other Cores within the CEG, and utilize the independent UC
Evaluation Services Center, will allow for the proposed objectives of the CEC to have local, regional, and
national impact.

Public health relevance
Project Narrative The Community Engagement Core (CEC) is a key integrating element in the University of Cincinnati (UC) Center for Environmental Genetics (CEG). The core has the major responsibility of assisting CEG members in fostering mutually beneficial, bidirectional partnerships with community members, health care professionals, and policy makers involved in environmental health science (EHS). The primary role of the CEC within the CEG is to increase awareness and understanding of EHS, serve as a liaison between the community and the Center, and ultimately develop strategies to reduce community exposures to hazardous environmental contaminants in order to improve public health.